NRSA Hepatology Training Grant

Project Summary/Abstract
The Postdoctoral Training Program in Hepatology is an integral part of the comprehensive hepatology research
program at UCSF. The purpose of the program is to provide trainees a solid background in liver biology and
disease and the investigational skills to address new questions and contribute to new knowledge in hepatology.
The program is staffed by 16 faculty based within the Departments of Medicine, Surgery, Pediatrics and
Bioengineering & Therapeutic Sciences; collectively these individuals offer balanced expertise in basic and
clinical hepatology and have a strong track record of working collaboratively with each other. A subgroup of six
program faculty comprise a Steering Committee charged with screening and selecting applicants, reviewing the
training curriculum and monitoring the progress of active trainees. An External Advisory Board provides
independent counsel. At the recruitment stage, faculty preceptors are trained to use holistic methods to screen
and select applicants in an equitable fashion. Faculty in charge of admitted trainees are educated in mentoring
best practices, including mentoring across differences. For the trainees themselves, the program prioritizes
structured individual development plans and encourages the use of mentoring teams that include career and
content mentors. The postdoctoral training plan begins with a foundational core curriculum covering liver biology,
liver-related research methods and general academic skills. Formal instruction in rigor, reproducibility and
responsible conduct of research is required. Along with this, trainees pursue specialized research instruction in
a selected topic area ranging from clinical epidemiology and health outcomes cell biology, immunology,
metabolism and fibrosis/carcinogenesis. Focused scientific coursework is available to all trainees if desired; for
those pursuing clinical investigation who do not have an advanced degree, enrollment in a Master’s Degree
program is mandatory. Commensurate with scientific training, postdocs receive support for career development
to facilitate their transition to independence. Importantly, the T32 program benefits from the rich research and
training infrastructure at UCSF that encompasses an array of core facilities as well as a wealth of resources for
trainee wellness and personal/professional support. Key among these are the UCSF Liver Center, the Clinical
and Translational Science Institute, the Office of Diversity and Outreach and the Office of Career and
Professional Development. Our program faculty are strong figures in several of these units, and accordingly they
can guide trainees to utilize the resources to maximize the value of their postdoctoral experience. The ultimate
goal of the training program is to provide sufficient group and individual mentorship to enable graduates to
assume a faculty-level position and compete successfully for independent research funding in hepatology.

Public health relevance
PROJECT NARRATIVE The UCSF Postdoctoral Training Program in Hepatology is designed to provide MD and PhD scientists the skills to conduct independent research relevant to the liver. The Program fills a need for basic and clinical investigators who will develop new knowledge to aid the prevention, diagnosis and treatment of liver-related ailments. The Training Program enables faculty to provide focused research instruction to 4 trainees per year. Importantly, it also enables trainees to enroll in didactic courses and obtain an advanced degree. The ultimate goal of the Training Program is for graduates to become independent investigators, meaningful contributors to the field of hepatology, and mentors themselves. The expectation is that the trainees’ research successes will translate into improved outcomes for patients suffering from liver diseases.